CYP2C11 Overexpression targeting peri-lesion astrocytes to improve cognitive function in mice with multi-infarct dementia

PROJECT SUMMARY
Multi-infarct dementia (MID), the most prevalent vascular cognitive impairment and dementia (VCID) subtype,
lacks disease-modifying therapies. Here, we propose a novel strategy to enhance cerebral blood flow (CBF) and
suppress neuroinflammation in MID. Astrocyte-derived epoxyeicosatrienoic acids (EETs), potent vasodilators
and anti-inflammatory mediators, are downregulated in response to hypoperfusion and hypoxia. Employing
adeno-associated virus (AAV) serotype PhP.eB driven by the glial fibrillary acidic protein (GFAP) promoter, we
propose to overexpress CYP2C11, a key EET-generating enzyme, specifically in peri-lesion astrocytes, via
utilizing the regional upregulation of GFAP in reactive astrocytes surrounding ischemic lesions. Localized EET
production will promote vasodilation, increase CBF in hypoperfused regions, and potentially improve cognitive
function. Additionally, EETs' anti-inflammatory properties can mitigate neuroinflammation, a key contributor to
MID progression. This targeted approach offers promise to improve therapeutic efficacy and to minimize off-
target effects of systemic vasodilators. We will test the following three specific aims in middle-aged mice: Aim 1
will determine the optimal dose of AAV-PhP.eB-GFAP-CYP2C11 on EET production, CBF, neuroinflammation,
and cognitive function in MID; Aim 2 will investigate the long-term effects of targeted CYP2C11 overexpression
in MID; Aim 3 will validate the causal contribution of targeted CYP2C11 overexpression on cognitive function in
MID. Our strategy presents a groundbreaking approach for MID treatment, with potential therapeutic impact on
other neurovascular disorders.

Public health relevance
PROJECT NARRATIVE This project will explore a novel strategy to improve cognitive function in multi-infarct dementia mice via AAV- mediated overexpression of CYP2C11 targeting peri-lesion astrocytes. CYP2C11 is a key generating enzyme of epoxyeicosatrienoic acids (EETs). Localized EET production will promote vasodilation, increase cerebral blood flow (CBF) in hypoperfused regions, and suppress neuroinflammation, thereby potentially improving cognitive function. Thus, AAV-mediated astrocyte overexpression of CYP2C11 may provide therapeutic benefit for a large patient population with a significant unmet medical need of dementia therapy.